HIV Vaccine Studies

This Vaccine Research Center (VRC) Clinical Trials Program (CTP) project is for clinical research related to preventive and therapeutic vaccines directed against HIV. Preventive HIV-1 vaccine candidates have included: DNA vaccine constructs, a recombinant adenoviral vector serotype 5(rAd5) vaccine, a recombinant adenoviral vector serotype 35 (rAd35) vaccine, and a trimer based vaccine with alum. Therapeutic vaccine candidates have included: DNA vaccine constructs and a recombinant adenoviral vector vaccine. Studies have been designed to evaluate dose, immunogenicity, route and device of administration, and prime-boost regimens.

VRC 001 (01-I-0079) evaluated a clade B, single plasmid DNA vaccine developed by the VRC in collaboration with other intramural investigators. Published: J Acquir Immune Defic Syndr, 2007. 44(5):p.601-5.

VRC 004 (03-I-0022) was the first Phase I clinical trial of a multiclade 4-plasmid DNA vaccine, VRC-HIVDNA009-00-VP, which expresses a Gag-Pol-Nef polyprotein from clade B HIV-1 and Env glycoproteins from clades A, B and C. This study evaluated the 2 mg, 4 mg and 8 mg dosage. Results published: J Infect Dis, 2006. 194(12):p.1650-60. Long-term follow-up was completed in FY08.

VRC 006 (04-I-0128) was the first Phase I clinical trial of an investigational recombinant serotype 5 adenoviral vector (rAd5) vaccine, VRC-HIVADV014-00-VP, for the prevention of HIV infection. This vaccine is composed of 4 adenoviral vectors (in a 3:1:1:1 ratio) that encode for the HIV-1 Gag/Pol polyprotein from clade B and HIV-1 Env glycoproteins from clades A, B, and C, respectively. This study evaluated three dosages. Results published: J Infect Dis, 2006. 194(12):p.1638-49. Long-term follow-up was completed in FY09.

VRC 007 (04-I-0254) was the first Phase I clinical trial of a multiclade 6-plasmid HIV-1 DNA vaccine, VRC-HIVDNA016-00-VP, which expresses Gag, Pol and Nef proteins from clade B HIV-1 and Env glycoproteins from clades A, B and C. The 4 mg dosage was evaluated. Published: Vaccine, 2007. 25(20):p.4085-92.

VRC 008 (05-I-0148) was a Phase I study of the prime-boost vaccination regimen consisting of 3 vaccinations with the 6-plasmid DNA vaccine followed by a boost with the rAd5 vaccine. This study evaluated the safety and immunogenicity of both Biojector and needle/syringe as injection devices for the DNA vaccine, as well as safety and immunogenicity of two different dosages for the rAd5 booster. The study was designed to enroll equal numbers of subjects with low and high antibody titers to adenovirus serotype 5. During FY08 week 94 long-term follow-up evaluations and analysis of the primary immunogenicity assays was completed. Published: PLoS One, 2013; 8(4):e59340.

VRC 009 (05-I-0081) was a Phase I study of the rAd5 vaccine as a booster vaccination in subjects previously immunized with the 4 mg or 8 mg dose of the 4-plasmid multiclade DNA vaccine in the VRC 004 study. Ten subjects enrolled. Similarly, VRC 010 (05-I-0140) was a Phase I study of the rAd5 vaccine as a booster vaccination in subjects previously immunized with 4 mg of the 6-plasmid multiclade DNA vaccine in the VRC 007 study. Only a small number of subjects were eligible to participate; 4 subjects enrolled and completed the 24 weeks of follow-up. Published: PLoS One, Feb 2010, 5(2):p.1-15

VRC 101 (06-I-0056) was the first Phase I therapeutic study of two candidate HIV-1 vaccines developed by the VRC and administered in a prime-boost regimen. Published: J Infect Dis. 2013 Jun 15;207(12):1829-40.

VRC 011 (06-I-0149) was a Phase I study to evaluate the intramuscular, subcutaneous and intradermal routes of administration for priming vaccinations with either 3 injections of the 6-plasmid DNA vaccine or one injection of the rAd5 vaccine. In all schedules a rAd5 booster injection was administered IM. Sixty subjects were enrolled; equal numbers of subjects had negative and positive antibody titers to adenovirus serotype 5 at enrollment. Follow-up of study participants was completed in FY 09. Published: PLoS One, 2014 Mar 12;9(3).

VRC 012 (07-I-0167) was a Phase I study to evaluate a novel prototype adenoviral vector serotype 35 vaccine (rAd 35-EnvA) at three dosages in Part I of the study and then in Part II of the study heterologous prime-boost schedules with an rAd5-EnvA vaccine will be evaluated. During FY08, Part I enrollments and vaccinations were completed. The enrollments and study vaccinations for Part II of the study were completed in FY10. Published: PLoS One. 2016 Nov 15;11(11).

VRC 015 (08-I-0171) was a Phase I study to evaluate the safety and immunogenicity of both Biojector and needle/syringe as injection devices for the recombinant serotype 5 adenoviral vector (rAd5) vaccine, VRC-HIVADV014-00-VP. Enrollments and study vaccinations were completed in FY10; long-term follow-up was completed in FY14. Published: PLoS One. 2014 Sep 29;9(9).

VRC 016 (11-I-0197) was a Phase Ib descriptive study to evaluate the kinetics and pattern of early innate and adaptive immune responses to the rAd5 vaccine, VRC-HIVADV014-00-VP, alone and after priming with a DNA vaccine. This study was initiated in FY11 and follow-up completed in FY14.

HVTN 505 (09-I-0163) was a multicenter Phase 2b efficacy study of the VRC candidate DNA prime-rAd5 boost HIV vaccine regimen for which the VRC Clinical Trials Core is participating as a site. After Phase 1/2 safety and immunogenicity evaluations of the vaccines were completed, this study was developed in collaboration with the Division of AIDS and HVTN and designed to see whether or not the vaccines have efficacy in prevention of HIV or an effect on HIV viral load in vaccine recipients as compared to placebo recipients who acquire HIV infection during 2 years of follow-up. Study enrollments were completed in FY13. Study vaccinations were discontinued in April 2013 based on DSMB recommendations when study results showed that prospectively defined efficacy futility criteria had been met. Long term follow-up is ongoing. Published: N Engl J Med. 2013 Nov 28;369(22):2083-92.

VRC 018 (19-I-0031) is a phase 1 dose escalation, randomized, open-label clinical trial to evaluate dose, safety, tolerability, and immunogenicity of an HIV-1 Env Vaccine, VRC-HIVRGP096-00-VP, (Trimer 4571) with alum in healthy adults. The trial was initiated in FY19 and enrollment was completed in FY 20. Trimer 4571 is the first prefusion-closed, stabilized HIV-1 Env trimer evaluated in humans. It was determined to be safe and well tolerated when adjuvanted with alum and administered by subcutaneous and intramuscular routes. Trimer-specific antibody responses detected two weeks after administration primarily focused on the glycan-free trimer base with no detectable responses to CD4 binding epitopes. Limited neutralizing antibody was detected which was also primarily directed to the glycan-free base of the trimer. This study informed future HIV vaccine efforts to determine how to induce effective neutralizing antibody responses against HIV in humans. EClinicalMedicine. 2022 Jun 1;48:101477. doi: 10.1016/j.eclinm.2022.101477. PMID: 35783486; PMCID: PMC9249552.

HVTN 303 is a Phase 1, open-label, dose escalation study to evaluate the dose, safety, tolerability, and immunogenicity of an adjuvanted HIV-1 Fusion Peptide (FP) conjugate vaccine (FP8v1-rTTHC) alone or in prime-boost regimens with adjuvanted HIV-1 Trimer 4571 and adjuvanted HIV-1 Trimer 6931 opened in July 2022. This is a multicenter trial sponsored by the Division of AIDS (DAIDS) and conducted by the HIV Vaccine Trials Network (HVTN) using vaccine products developed by the VRC. VRC Clinical Trials Program (CTP) physicians are members of the HVTN 303 protocol team, serve as VRC product representatives, and participate in protocol safety review team meetings.